Es Tiempo/It’s Time: A Multi-Channel Multi-Cultural Communication Campaign for Improvements in Education and Outcomes on Human Papilloma Virus Vaccinations and HPV Related Cancers in Vulnerable popula

Abstract
Although much progress has been made with the Human Papilloma Virus (HPV) vaccine, still some communities
lag in HPV vaccination rates. Reasons for this vary. HPV vaccination is lowest among
Hispanic/Latinos/Latinas(H/L), Asian adolescent boys and H/L adolescent girls of non-US-born parents and for
adolescents of African immigrant parents living in the U.S. These include indigenous groups from Latin America
(Amerindians) and Africa (Ethiopians, Nigerians, Senegalese) In Los Angeles. LA data show one-fifth of parents
from H/L, African ancestry, and Chinese American families (n = 357) high HPV vaccine resistance and over 50%
worried about safety or side effects. Research shows
low health literacy on HPV related factors, vaccine
misconceptions are important factors contributing to low vaccine uptake in these groups.
Further, though HPV is
not gender-specific, the feminization of HPV with a focus on cervical cancer has been impacted by its sexual
transmissibility; and this in turn has influenced the acceptance of HPV related information and its application
among boys and men, especially lacking has been information on other HPV related cancers and culturally
tailored, age appropriate and in language materials for immigrant origin groups. The USC Norris Comprehensive
Cancer Center (USC NCCC) proposes to work on Track 1 (youth and adolescents) to develop and test a
communication campaign with culturally and age-tailored educational materials on HPV related cancers and
promote initiation of the HPV Vaccine among both male and female adolescent/young adults (10-30ys) in the
HL, Chinese and African American/African-origin immigrant communities. We will collaborate with community
partners Barrio Action Youth Center, Celebrate Life Black Churches Ministry, Vision y Compromiso, and 7 local
FQHC clinics part of Clinicas Monsenor Oscar Romero, and the Chinatown Service Center (CSC), and Vision y
Compromiso (promotores de salud). Leveraging USC NCCC Cancer Center COE resources and informed by
findings from our previous administrative supplement (Tsui/Baezconde-Garbanati) we will extend our reach to
both male and female vulnerable adolescents/young adults (AYA) in diverse audiences. Both quantitative (pre
and post campaign) and qualitative data from listening sessions and focus groups will support development of
campaign elements and its evaluation. Cultural experts and age-appropriate experts (including adolescents), our
Community Advisory Committee and partners will support campaign development. We will use Artificial
Intelligence (AI) technology/platforms to produce age and culturally appropriate educational materials in
language. Proof of vaccinations will be via medical records review and reports by our FQHC clinics regarding
consented participants. Community partners will help identify, train, and establish a community workforce
composed of community health educators and promotores de salud for dissemination.

Public health relevance
Project Narrative Despite tremendous progress in reductions in cancer with the Human Papilloma Virus (HPV) vaccine, HPV- related infections in vulnerable communities and vaccine initiation still lag contributing to pervasive cancer disparities. The ET-MICEO HPV campaign will reduce disparities by enhancing knowledge on HPV-related cancers and promoting initiation of the HPV vaccine among adolescents and young adult males and females in the Hispanic/Latino, Chinese, and African Americans/African immigrant communities.